Role of ASTN2 in Cerebellar Circuit Function and ASD-related Behaviors

PROJECT SUMMARY
The proposed research addresses a critically important question in autism spectrum disorder (ASD)
research: how defects in cerebellar circuits contribute to ASD. In particular, it examines the role of the
predominantly cerebellar gene ASTN2 in cerebellar circuit function and ASD-related behaviors. Copy
number variations (CNVs) in ASTN2 have been identified as a significant risk factor for ASD (Lionel et
al, 2014), suggesting that ASTN2 mutations such as those found in patients with ASTN2 CNVs, lead
to altered cerebellar synaptic function. In addition, we recently reported a family with a paternally
inherited intragenic ASTN2 duplication, which caused a heterozygous loss of function of ASTN2. The
family manifested a range of neurodevelopmental disorders, including ASD, learning difficulties and
speech and language delay (Behesti et al, 2018). Our cellular and molecular studies on mouse
cerebellum show that ASTN2 binds to and regulates the trafficking of multiple synaptic proteins,
including Neuroligins, which have been genetically linked to ASDs, and modulates cerebellar Purkinje
cell (PC) synaptic activity (Behesti et al, 2018). To provide a genetic model to study cerebellar circuit
function, we generated both a global loss of function Astn2 line and a floxed Astn2 line for conditional
knockout experiments. New, preliminary evidence indicates that PCs in mice lacking Astn2 have a
decrease in evoked excitation relative to inhibition in PCs and reduced PC dendritic spine density,
suggesting specific cerebellar circuit defects. In addition, preliminary evidence shows mild motor
deficits and defects in USVs and an open field assay, ASD-related behaviors. As other preliminary
findings do not indicate major defects in cerebellar development, we hypothesize that the behavioral
defects we observed relate to defects in the cerebellar circuitry with underlying changes in receptor
trafficking.
In the proposed research, we will 1) test how loss of Astn2 alters intrinsic excitability in PCs and
the synaptic efficacy of their presynaptic inputs from GCs and molecular layer interneurons, 2) use
proteomics to identify changes in the levels of synaptic proteins and live imaging to assess whether
such changes relate to changes in the rate of endocytosis, 3) compare changes in PC dendritic
branching as well as the regional distribution of PC spines in wild type and mutant animals to provide
insight on whether there are changes in the organization of PC inputs during the establishment of the
cerebellar circuitry, and 4) analyze changes in social behavior and ultrasonic vocalization in Astn2 wild
type, heterozygous and mutant animals. Taken together, the proposed research will provide a new
mouse model that allows us to link an ASD-related gene that is predominantly expressed in the
cerebellum with specific cerebellar circuit function and molecular pathways.

Public health relevance
PROJECT NARRATIVE The proposed research addresses a critically important question in autism spectrum disorder (ASD) research: how defects in cerebellar circuits contribute to ASD. Neurogenetic studies demonstrate that CNVs in the predominantly cerebellar gene ASTN2 are a significant risk factor for ASD. The proposed research will use a novel mouse model lacking Astn2 that we generated to analyze changes in cerebellar circuit function, synaptic proteins, organization of synaptic inputs and ASD-related changes in social behavior and communication.